Identifying and Testing Post-Overdose Outreach Adaptations to Enhance Survivor Engagement During the COVID-19 Pandemic

PROJECT SUMMARY / ABSTRACT
As the leading cause of accidental injury death, overdose remains a critical public health challenge that has
worsened in the midst of the COVID-19 pandemic. Engaging overdose survivors in OEND and MOUD presents
a key opportunity to reduce subsequent fatal overdose. In response to the opioid overdose epidemic,
community post-overdose outreach programs, which typically include partner public health and public safety
professionals to follow-up with overdose survivors in-person, have emerged to engage overdose survivors in
OEND and MOUD. With the onset of the COVID-19 pandemic, most post-overdose programs suspended or
initially reduced their contact with overdose survivors and, then, adapted their outreach activities to continue
their engagement with high-risk overdose survivors. These innovations included telephone and texting contact,
distributing phones to those without, drop-off distribution of OEND kits and masks, and telemedicine
partnerships for low barrier MOUD initiation. Identifying, describing, and testing these innovations is crucial to
understand how to best engage overdose survivors in the midst of the COVID pandemic and beyond. In this
R21, we propose a two-year plan to identify and describe innovative post-overdose engagement strategies
developed during the COVID-19 pandemic, and to pilot test a toolkit of the most promising adaptations. The
specific aims are to identify innovative adaptions in response to the COVID-19 pandemic through a statewide
survey (Aim 1), describe mechanisms of action that promote or impede successful COVID-19 related
adaptations through 30 qualitative interviews of overdose survivors and post-overdose outreach staff (Aim 2),
and pilot test a toolkit of the most promising COVID-19 adaptive strategies within one post-overdose outreach
program to increase the number of overdose survivor contacts, naloxone rescue kits provided, and referrals to
MOUD (Aim 3). Guided by the PARiHS framework, our mixed-method approach will provide critical insight on
what has promoted or impeded success of COVID-19 related adaptations and enable successful and
sustained change during the COVID-19 pandemic and beyond. Our ultimate goal is to develop an effective,
community-level post-overdose outreach intervention toolkit that reduces opioid overdose fatalities via
engaging overdose survivors in OEND and MOUD that is resilient to the COVID-19 pandemic’s social and
economic challenges.

Public health relevance
PROJECT NARRATIVE With mandated social distancing and healthcare service disruptions due to the COVID-19 pandemic, there is an urgent need to better understand how people at high-risk for overdose are engaging with and receiving overdose education and naloxone distribution (OEND) and medication for opioid use disorder (MOUD). We propose to understand how post-overdose outreach programs, which typically provide OEND and MOUD linkage, have adapted their programming during the COVID-19 pandemic and to pilot test a toolkit of the most successful adaptations. Our findings will be critical to the development of effective and sustainable post- overdose outreach adaptations to the COVID-19 pandemic.